Environmental risk factors for uterine fibroids: a prospective ultrasound study

ABSTRACT
Uterine leiomyomata (UL), or fibroids, are neoplasms of the myometrium that are associated with heavy
menstrual bleeding, anemia, pelvic pain, infertility, and complications of pregnancy and delivery. In the United
States (U.S.), UL are diagnosed in 25%-30% of reproductive-aged females and they are the leading indication
for hysterectomy. Black women are disproportionately affected by UL, experiencing greater incidence, earlier
age at first diagnosis and surgery, and greater disease severity on average than White women. Factors
associated with UL incidence, growth, and symptom severity are poorly understood. Not all UL patients
experience the same symptoms, and the relation of UL characteristics (e.g., size, number, location) with
symptom severity and quality of life has not been well studied. Since its inception in 2010, the NIEHS-funded
Study of Environment, Lifestyle and Fibroids (SELF) has carried out nearly 8,000 clinic visits during a 10-year
period among >1600 Black females living in the Detroit area with the goal of defining the natural history of UL
and identifying risk factors for UL incidence and growth (R01ES028235: funding completed 8/2022). This cohort
of minority participants who are underrepresented in scientific research has >85% retention during approximately
10 years of follow-up. Data from SELF participants have already produced 58 peer reviewed publications. The
present R01 renewal application will extend the follow-up of the cohort for another 5 years (incident period: 15
years) with an additional (6th) clinic visit, which will again involve performing transvaginal ultrasounds to map and
measure UL among new and existing cases, collect biospecimens, and gather detailed covariate data via
interview. These new data, combined with data from both completed and soon to be completed analyses of
biological samples from prior SELF study visits, will be used to achieve the following specific aims: 1) Describe
changes in UL incidence and characteristics (size, number, location) during a 15-year period; 2) Determine the
relationship between UL characteristics and UL symptom severity as ascertained by the UFS-QOL, a validated
UL-specific quality of life questionnaire; and 3) Build on our previous work by evaluating a broader set of
biomarkers of environmental chemicals and/or their metabolites in blood and urine from targeted panels (e.g.,
heavy metals, PCBs, PFAS, PBDEs, phthalates, phenols) and untargeted metabolomics to identify exposures
associated with UL incidence and growth during a longer incident period (up to 15 years). We will use flexible
approaches to evaluate non-linearity and assess interaction between exposures. As SELF participants were
ages 23-35 years at enrollment and are nearing peak age of UL incidence (40-45 years), the ongoing study of
cohort members is extremely valuable. With its prospective study design, serial ultrasounds, repeated collection
of data on exposures and covariates, interdisciplinary research team, and inclusion of a highly-engaged study
population, the SELF cohort is ideal for defining the natural history of UL and the environmental factors that
influence it in a population disproportionately affected by the condition.

Public health relevance
Uterine leiomyomas (UL), also known as fibroids, are the leading cause of hysterectomy in the United States. These benign tumors, which are more common among Black individuals, can cause heavy menstrual bleeding, pelvic pain, and infertility. This project will examine the age distribution of when UL occur, the extent to which UL characteristics (size, number, location) predict symptom severity, and environmental factors associated with UL occurrence and growth in a cohort of Black individuals during a 15-year period.